Core 1: Diabetes, GI & Nutrition, Ziegler

PROJECT SUMMARY – Core 1: Diabetes, GI, and Nutrition Core
Major advances in the management of pulmonary disease in cystic fibrosis (CF) have led to a needed redirection
of research to non-pulmonary comorbidities. Critical knowledge gaps exist in three key areas: 1) chronic
endocrine complications, including CF-related diabetes (CFRD); 2) gastrointestinal (GI) and hepatic
manifestations, including CF-related liver disease (CFLD); and 3) assessment and optimization of nutritional
status. Individuals living with CF commonly experience comorbidities in one or more of these domains that
significantly impair their overall quality of life and can reduce their long-term survival. In addition, little research
has yet been conducted relevant to endocrine, GI, or nutritional issues in CF patients receiving CFTR modulators.
The major goal of the Diabetes, GI, and Nutrition (DGN) Core of the Georgia CF Research and Translation Core
Center (Georgia CF Core Center) is to support the research and training of clinical and translational scientists in
non-pulmonary, NIDDK mission-related research in children and adults with CF. The DGN Core will consist of
three integrated Sub-Cores, each providing unique and complementary faculty expertise and resources. These
are: 1) Diabetes/Endocrine Sub-Core, 2) GI/Liver Sub-Core, and 3) Nutrition Sub-Core. The nature of the
research supported by the DGN Sub-Cores is conducive to integrative interactions between each Sub-Core and
with all other activities in our proposed Georgia CF Core Center. Each DGN Sub-Core will provide novel serial
data obtained from annual research oral glucose tolerance test visits in children and adults with CF to the Georgia
CF Data Warehouse, a state-wide data repository proposed by the Clinical Research and Informatics Core. We
hypothesize that the DGN Core will lead to: 1) more impactful CF research; 2) more investigators new to CF
performing multi-disciplinary research; 3) new collaborations linking DGN Core leadership and users to internal
and external CF investigators; and 4) earlier detection, better diagnostics, and better treatment of CF
comorbidities. We propose four specific aims to meet the goals of the DGN Core:
Specific Aim 1: To provide a novel platform for established and new CF investigators wanting to incorporate
diabetes, bone, sex/reproductive health, and other endocrine endpoints into their research (Diabetes/Endocrine
Sub-Core).
Specific Aim 2: To aid CF investigators interested in CF GI/liver disease with access to state-of-the-art tools
and measurements, study design guidance, and data interpretation services (GI/Liver Sub-Core).
Specific Aim 3: To provide scientists performing CF research with access to state-of-the-art tools and
measurements, study design guidance, and data interpretation services related to nutrition and body composition
outcomes (Nutrition Sub-Core).
Specific Aim 4: To provide education, training and critical new outreach to promote interest and maximize DGN
Core usage for clinical and translational research in CF across the lifespan.